PACES: Practical Approaches to Care in Emergency Syncope

Project Summary/Abstract
The goal of this project is to improve risk-stratification for patients who present to the emergency department
(ED) with syncope (transient loss of consciousness), in order to better delineate which patients require
admission and which can be safely discharged home. Syncope and pre-syncope (the sensation of impending
loss of consciousness) are common reasons to present to the ED, representing over 1.3 million visits per year
in the United States.
Although syncope is most often benign, it can occasionally be caused by serious cardiopulmonary diseases
such as cardiac arrhythmia, acute coronary syndrome, or pulmonary embolism. Despite thorough evaluation in
the ED, the cause of syncope remains unknown in over 50% of cases, which leads to a large number of
syncope patients being admitted for observation and/or further testing. These admissions to the hospital or
observation unit are low-yield, costly, and expose patients to the possibility of iatrogenic harm.
In response to this, two groups of researchers have developed distinct syncope risk-stratification tools: the
US Syncope Risk Score and the Canadian Syncope Risk Score. These scores use a combination of clinical,
electrocardiographic, and laboratory variables to predict the risk of serious clinical outcomes at 30 days. While
promising, these two risk scores require external validation prior to widespread clinical implementation. In Aim
1 of this proposal, we will prospectively collect data on ~1,370 ED patients with syncope/pre-syncope and
follow them for 30 days to validate the predictive accuracy of these two risk scores. In Aim 2, we will assess
the impact of implementing these scores by measuring their potential effect on healthcare utilization and costs.
Existing care will be used as the reference strategy and will be compared with a simple risk-based clinical
algorithm: Direct discharge for low risk patients (under 2% risk of serious outcome at 30 days), and
hospitalization for medium- and high-risk patients.
If validated and shown to safely reduce healthcare utilization, these syncope risk scores could play a major
role in improving emergency syncope care by reducing low-yield admissions and identifying patients who are
unsafe for discharge from the ED. This study, entitled PACES: Practical Approaches to Care in Emergency
Syncope, will help increase the quality and value of emergency care, and advance the field of syncope
research.

Public health relevance
Project Narrative Syncope, or transient loss of consciousness, is a common reason for visit to the Emergency Department and often leads to extensive testing and hospitalization. Using objective risk scores to determine which patients with syncope will actually benefit from these interventions, and which can be safely discharged home with minimal testing, is critical to providing sensible medical care. Our study will evaluate the validity of two syncope risk-stratification tools and investigate their impact on healthcare utilization and patient safety, thus improving the quality of care for the 1-2 million patients who experience syncope every year in the United States.